Alzheimer's Disease: New Trial Designs for Emerging Challenges

Project Summary/Abstract
Alzheimer’s disease (AD) is characterized by heterogeneity in sex, race, APOE ε4 status, and tau. APOE ε4
status has been used to stratify AD patients in clinical trials (e.g., the aducanumab trial). Women with AD
have faster cognitive decline compared to men with AD from longitudinal studies. African Americans decline
faster than Whites on memory tests and visuospatial functioning. Furthermore, we know that the changes
in cognitive functions are negatively associated with tau levels. In addition to the heterogeneity, another
challenge facing AD trials is the follow-up time in study designs. In the recent aducanumab trial, the dose of
aducanumab was increased during the course of the study for APOE ε4 positive patients, but their follow-up
times remained unchanged. The proposed project will respond to PAR-19-070: Research on Current Topics in
Alzheimer’s Disease and Its Related Dementias. We will develop adaptive designs to allow the modiﬁcation
of follow-up time for patients with dose change in Aim 1. The published results from the aducanumab trial
will be used in simulation studies to compare the statistical performance of the proposed adaptive designs
with the existing designs without follow-up time change. Our simulation results indicated that our proposed
adaptive designs guarantee the type I error rate and power, while the existing designs do not. In Aim 2,
we will develop new optimal composite scores for each subpopulation by using the baseline data and the
rate of change over time to better understand the differences in cognition and trajectories of decline. We
will develop one optimal composite score for each subpopulation stratiﬁed by sex, race, APOE ε4 status, and
tau, based on data from the ADNI study. We will demonstrate how best to manage statistically the effects
of demographic, genetic, and biomarker factors on cognitive ability of AD patients. The optimal composite
scores are expected to be more sensitive to detect cognition change compared to the measures we traditionally
use. In 2019, the Food and Drug Administration released a ﬁnal guidance on developing enrichment strategies
in clinical investigations to promote innovation in drug development. Treatment effect heterogeneity exists
among patients with different characteristics. Identifying subpopulations who are more likely to respond to
a new treatment at a given dose would signiﬁcantly increase the success rate of AD trials and avoid the types
of issues that occurred in the aducanumab trial. Adaptive enrichment designs for AD trials will measure
the treatment effectiveness of each subpopulation at the interim analysis for futility based stopping, and can
save sample sizes compared to the existing designs. We will add a constraint on the probability of ‘wrong’
stopping for futility to avoid stopping the enrollment for a possible effective treatment on a subpopulation.
This project will provide new statistical tools for AD research to efﬁciently identify individuals at risk of AD
and quickly detect disease progression for AD patients with different characteristics.

Public health relevance
Project Narrative Treatment effect heterogeneity exists among patients with different characteristics including demographic, ge- netic, and biomarker risk factors. The proposed optimal composite scores will increase our ability to measure outcomes in AD and can be applied directly to personalized AD treatments. The proposed adaptive designs will improve the ﬂexibility of trial designs which would provide greater efﬁciency in AD drug development.